TRIAL OF PERIPHERAL BLOOD STEM HARVEST FOR AUTOLOGOUS BONE MARROW TRANSPLANTATION

The goal of this protocol is to perform Autologous BMT in patients for whom marrow donation is not possible. Peripheral blood stem cells obtained by leukophoresis are used.